Understanding the Efficacy of T-TEER in Models of Primary Tricuspid Regurgitation

PROJECT SUMMARY
Tricuspid valve regurgitation (TR) is a common valve disease that, if severe, leads to high morbidity and mortality.
Until recently, many patients, even those with severe TR, remained untreated due to high operative risks. This
undertreatment has been declared a “public health crisis.” The introduction of transcatheter technologies for
tricuspid valve repair has reduced operative risks and offers the potential to overcome this crisis. Among them,
transcatheter tricuspid edge-to-edge repair (T-TEER) has taken the lead, with many centers performing it
routinely. Notably, most guidelines recommend T-TEER only for patients with secondary TR. That is, TR that is
caused by other primary diseases. However, similar to other transcatheter technologies, increased confidence
in the technology is slowly expanding the eligible patient populations. For example, a recent explorative study
has tested the feasibility of T-TEER in patients with primary TR due to defective leaflets, including prolapsed and
flail tricuspid valves. Being an explorative clinical study, efficacy-critical parameters could not be isolated and
studied in a controlled setting. Without such basic scientific experiments, much remains to be understood and
tested before recommending T-TEER to this increased patient population. The objective of this predoctoral
fellowship application is to test the hypothesis that successful T-TEER in models of primary TR requires
a defect-specific choice of procedural parameters. Therein, I explore defect type, size, and location and
adjust clip location, size, and number. Confidently exploring this large parameter space is not feasible using
in vitro experimentation in explanted hearts alone. To this end, I will combine experiments in porcine and human
hearts and high-fidelity in silico computer simulations. I will first conduct in vitro T-TEER experiments in hearts
with induced primary TR. I will use these experimental data to build and validate a baseline set of computational
tricuspid valve models. Finally, from this baseline set I will produce an additional 100 “synthetic” (i.e., computer-
generated) tricuspid valve models. In these models, I will conduct virtual T-TEER procedures. This approach
allows testing hundreds of real and “synthetic” valve anatomies, pathologies, and procedures. Thereby, I can
explore many more parameter combinations than would be possible with in vitro experiments alone. My aims
are twofold: 1) experimentally test T-TEER success in prolapsed and flail tricuspid valves, 2) build,
validate, and use simulations to test T-TEER success in valves with primary TR. At the conclusion of this
project, I will have tested whether the efficacy of T-TEER for patients with primary TR requires defect-specific
procedural parameters. Furthermore, my study will address limitations of current clinical studies, which have left
critical scientific questions unanswered. My scientific findings will contribute to the current literature and inform
future guidelines for T-TEER treatment selection.

Public health relevance
PROJECT NARRATIVE Primary tricuspid regurgitation is a disease in which damage to the valve leads to leakage of blood into the right atrium. Because open heart surgery is risky, novel minimally invasive transcatheter technologies have been developed to treat tricuspid valve leakage. However, little is known about the applicability of these technologies to primary tricuspid regurgitation, a knowledge gap I aim to overcome with this proposed research.